Functional characterization of cell surface RNA biology

PROJECT SUMMARY / ABSTRACT
The composition and organization of the cell surface are critically important for cell-to-cell communication and
for the ability of cells to interact with their surrounding environment. The cell surface is decorated with myriad
glycosylated transmembrane proteins for which there is a molecular understanding of their function and cell
surface presentation. Surprisingly, RNA and RNA-binding proteins (RBPs) are also glycosylated and
components of the cell surface. However, is unknown what glycosylated RNAs and RBPs do at the cell surface.
This unexplored area of biology represents a major knowledge gap in our understanding of both the RNA and
cell surface fields. Thus, the immediate goal of this proposal is to close this knowledge gap and to create the
conceptual and technical foundations that will enhance our understanding and exploration, respectively, of the
biology of RNA at the surface of the cell. To achieve this, we propose to explore three fundamental, but
outstanding, hypotheses. Importantly, these hypotheses are established on sound logic of the known biology of
RNA and RBPs and supported by the published literature and preliminary data. Hypothesis 1 explores the
molecular, biochemical, and biophysical activities of the cell surface localized RBPs DDX21 and NCL in the
extracellular space. Hypothesis 2 takes an unbiased genetic approach to determine how cell surface RBPs are
trafficked to the cell surface, given that they lack a classical membrane-targeting signal. Hypothesis 3 explores
the intersection between cell surface RBPs and RNA in disease pathogenesis by focusing on the functional
characterization of cell surface RBPs that possess cell-penetrating activities. The expected outcomes of this
research are to reveal that the biochemical activities of RBPs are not restricted to the intracellular space of the
cell, but also to the cell surface. The significance of the proposed research lies in expanding the field of RNA to
the surface of cells and providing proof of concept of the importance of cell surface RBPs in human disease.
While high-risk, the proposed research addresses an important problem and has the potential to be
transformative. Hence its suitability for the Transformative Research Award.

Public health relevance
PROJECT NARRATIVE RNA is a central regulator of cell biology, canonically considered an intracellular regulator, unable to directly interface with the extracellular space. Bolstered by recent evidence of cell surface RNAs and glycosylated RNAs, as well as long-standing but poorly characterized examples of a small set of cell surface RNA binding proteins, we aim to define a new paradigm, one where RNA biology is a common and functional component of the cell surface. Our work will establish foundational tools, mechanisms, and functions for cell surface RNA biology, enabling others to build on our observations and update the molecular models of what molecules are present on the surface of cells.